Enhancing Perinatal Care Support to Improve Maternal Mortality Disparities

ABSTRACT
Persistent and worsening racial and ethnic disparities in severe maternal morbidity and mortality in the US are
urgent public health concerns requiring innovative, sustainable solutions. The perinatal period, the time before
and after birth, has important implications for a woman’s health and that of her child. Unfortunately, standard
perinatal care fails to meet the needs of women from Black, Indigenous and People of Color (BIPOC)
communities, especially with consideration to the Social Determinants of Health (SDoH) and the systemic racism
that drive health disparities. Doula care is increasingly recommended to support high-risk BIPOC women during
labor and the immediate postpartum period and is posited to mitigate the effects of racism and SDoH in
underserved populations. However, a key limitation to doula care is that doulas are largely relegated to working
in parallel with the healthcare team and the potential consequences of this include disjointed care coordination
and missed opportunities to improve healthcare quality for BIPOC women. Building on our team’s prior and
current work optimizing perinatal care for medically underserved women, we will develop and evaluate a Well-
Mama intervention in 3 participating medical centers in Chicago IL, Baton Rouge LA, and Newark NJ which have
some of the highest US rates of maternal morbidity and mortality. The Well-Mama intervention is centered on
uninsured and publicly insured pregnant and postpartum BIPOC women supported by Community Doula
Navigators (CDNs) who will conduct in-person and telehealth wellness check-ins using the Well-Mama safety
checklist; make referrals to resources following the check-ins, with feedback provided to the perinatal care team;
lead virtual pregnancy and postpartum support groups; attend select patient visits; and provide labor support.
The Well-Mama checklist includes 5 priority topic areas representing leading factors in maternal morbidity and
mortality in which to attune doulas and their patients: (a) mental health/depression; (b) cardiovascular symptoms;
(c) safety (e.g., guns at home and intimate partner violence); (d) opioid/substance abuse; and (e) social support,
self-agency, and well-being. Well-Mama advances a Shared Care Model approach to health care delivery
focused on interprofessional collaboration in relation to centering care on the individual patient. Through a Hybrid
Type 1 randomized effectiveness-implementation trial of N=576 women, we will compare the effectiveness of
the Well-Mama intervention relative to standard perinatal care in improving women’s receipt of recommended
care components (primary outcome), reducing patient medical distrust and experience of racism/discrimination,
increasing health engagement, self-efficacy, and perception of care team quality, and enhancing perinatal care
team cohesion (secondary outcomes), while evaluating intervention implementation. Results will optimize doula
integrated perinatal care to address the top drivers of maternal morbidity and mortality with the goal of reducing
maternal health disparities experienced by pregnant and postpartum BIPOC women.

Public health relevance
PROJECT NARRATIVE Black, Indigenous, and People of Color (BIPOC) women experience profound maternal health disparities in the US, including rising rates of maternal mortality and severe maternal morbidity. This study will develop a Well- Mama intervention for pregnant and postpartum BIPOC women, centered around Community Doula Navigators conducting in-person and telehealth check-ins on 5 priority areas (mental health, cardiovascular symptoms, safety, opioid/substance abuse, and social support), supplemented with virtual support groups and labor support. We will conduct a randomized trial in Chicago IL, Newark NJ, and Baton Rouge LA to test whether the Well- Mama intervention increases BIPOC women’s receipt of prenatal and postpartum care.